Cold Spring Harbor Laboratory Cancer Workshops

The Cold Spring Harbor Laboratory proposes to continue three courses in
Molecular Biology, Molecular Genetics and Biochemistry, whose methodologies are
important for modern cancer research, to be held in 2017 – 2021. These short, intensive
courses include Expression, Purification & Analysis of Proteins and Protein
Complexes (two weeks), Mouse Development, Stem Cells & Cancer (three weeks)
and Chromatin, Epigenetics and Gene Expression (three weeks). Each course
prepares the student to enter directly into research that makes use of advanced and/or
specialized techniques and concepts that can be applied to studies of growth and
regulation of normal eukaryotic cells and their oncogenic counterparts. Each course has
a different emphasis and serves a different need. The course in Expression, Purification
& Analysis of Proteins and Protein Complexes seeks to train students in the theory and
practice of methods of protein expression, purification and analysis. These methods can
be used for the characterization and production of proteins and protein complexes
implicated in cancer, including oncogenes, tumor suppressor genes, and signaling
molecules and cascades. The course on Mouse Development, Stem Cells & Cancer
trains scientists to study gene regulation and development in the context of the whole
organism, as well as mouse models of human disease such as cancer. The course
provides in intensive hands-on introduction to engineering of mouse models, stem cell
technologies and tissue analyses. Lectures provide the conceptual basis for
contemporary research in embryogenesis, organogenesis in development and disease,
embryonic, adult and induced pluripotent stem cells and cancer biology. The course on
Chromatin, Epigenetics and Gene Expression aims to expose students to a broad array
of methodologies to study gene regulation, chromatin structure and dynamics, including
both well-developed and cutting edge methods, such as RNAi, CRISPR and
chromosome conformation capture. The faculty is chosen on the basis of their
contributions to and knowledge of the field covered in each course. The faculty invite
lecturers who give up-to-the-minute reports on current research. The lecturers have all
made significant contributions to their fields. The trainees range from graduate students
to senior investigators who are chosen by the course faculty from a large number of
applicants. Because of the short duration of the courses, senior, as well as junior,
individuals can attend and receive an intense period of training in an environment
remote from other demands on their on their time and attention. The courses provide an
unusual opportunity for scientists to retrain in another specialty or to apply the work of a
new field to their own research.

Public health relevance
Modern cancer research requires investigators who are skilled in a wide variety of advanced and innovative laboratory techniques in gene expression, protein biochemistry and the development of mouse models. These Cold Spring Harbor annual short courses offer specialized training in a residential setting that immediately impacts the progress of the trainees' research. The courses also promote collaboration and exchange of ideas between faculty and trainees, and thus represent a significant and valuable investment towards accelerating cancer research by educating select cadres of researchers in the latest methods and concepts in these disciplines.